The Impact of Late Preterm Steroids in Reducing Neonatal Respiratory Morbidity in the US

Project Summary
In the US, 280,000 infants are born in the late preterm period (34-36 weeks of gestation) each year, and there
are marked disparities in preterm birth rates among racial and ethnic groups. Respiratory morbidity remains a
leading cause of complications resulting from prematurity; among late preterm births, 10% of neonates will
experience respiratory complications. The Antenatal Late Preterm Steroids Trial, a randomized controlled trial
(RCT) of 2,831 individuals at risk for late preterm delivery, demonstrated that antenatal steroids reduced severe
neonatal respiratory complications by 34%. However, routine administration of antenatal late preterm steroids
(ALPS) remains underutilized in the US due to the controversy surrounding which populations experience the
greatest respiratory benefit in relation to the potential risks. The lack of granular efficacy data has divided
clinicians about when to offer ALPS, curtailing its full-scale adoption and leading to heterogeneous use across
the US. The overall objective of the project is to reduce preventable neonatal respiratory morbidity by generating
clinical evidence that is urgently needed to help obstetricians, neonatologists, and policymakers reach a
consensus on appropriate ALPS administration in the US. First, to inform quality monitoring efforts, we will
identify patient and hospital factors associated with an individual’s likelihood of receiving ALPS and quantify the
proportion of hospital-level variation that remains unexplained by these factors (Aim 1). Next, we will leverage
hospital-level variation in ALPS use to estimate the effectiveness of ALPS outside the clinical trial setting using
a difference-in-differences (DID) design (Aim 2). The study team has considerable experience with this approach,
which involves conceptualizing the differential adoption of ALPS as a natural experiment and can be used to
estimate unbiased causal effects even in the presence of unmeasured confounders, which biases traditional
cohort study designs. Last, we will rely on the technical expertise of the NCI’s cancer modeling consortium to
develop and validate a microsimulation model for late preterm birth. This approach will allow us to examine how
policies designed to increase ALPS utilization could reduce respiratory morbidity and other neonatal outcomes
(e.g., hypoglycemia episodes, NICU admissions) among late preterm births in the US using this comprehensive
simulation modeling framework (Aim 3). To complete this work, we will draw on data from the ALPS RCT, US
vital statistics, and patient- and hospital-level information from the Premier Healthcare Database (PHD), an
existing data set that includes information on the care of nearly 1 million births from >800 hospitals annually
(25% of all US births). The multi-disciplinary team’s expertise in clinical obstetrics and neonatology, health
services research, quasi-experimental methods, and simulation modeling has uniquely positioned our team to
address these critical gaps. Results from this study will have direct, immediate, and actionable implications for
the individuals at risk of late preterm delivery and their neonates, their families, clinicians, and policymakers.

Public health relevance
Project Narrative Respiratory morbidity remains a leading cause of prematurity-related complications among late preterm births. Lingering uncertainty of the true real-world benefit and the lack of granular efficacy data have left clinicians divided about when to use ALPS, curtailing widespread adoption and resulting in preventable neonatal respiratory morbidity. This project will address these remaining knowledge gaps and propose actionable solutions for clinicians, hospitals, and policymakers to reduce respiratory morbidity among late preterm births through increased use of antenatal steroids.